Core B: Human Pancreas

ABSTRACT: Stanford Human Bio-bank for Pancreas Cancer Research (Core B)
The Stanford Human Bio-Bank for Pancreas Cancer Research (Core B) will support human tissue and cell
studies proposed in the Projects of this Program Project Grant whose overall goal is to systematically clarify the
genetic drivers of PDAC pathogenesis and define the immune system's role in pancreatic cancer propagation.
While many studies will be performed in defined genetically engineered mouse models of PDAC, an important
theme of these studies is to test and demonstrate the relevance of our discoveries to human PDAC. With this
objective, this Core will 1) Systematically collect and bank human pancreatic cancer tissues and blood, and to
establish a registry of clinical and demographic information of these patients, 2) Systematically collect and bank
human pancreatic tissue and blood from patients with chronic pancreatitis and to establish a registry of clinical
and demographic information of these patients, 3) Provide expertise and knowledge of human tissue analysis
by histology, immunohistochemistry, FACS, CyTOF, and single-cell RNASeq, and 4) Collaborate effectively with
Core C to use CODEX for studies on human tissues for all Projects. This Core will support Project 1 by providing
human pancreatic cancer tissue, pre-cancerous pancreatic lesions, and chronic pancreatitis (CP) samples for
evaluation of their genetic diversity in the KRAS oncogene, and tumor suppressor genes. This Core will support
Project 2, by providing pancreata from patients with PDAC, or inflammatory states like CP, to assess immune
and fibroblast subtypes, IL-22/ IL-22RA1 expression patterns and in the context of PDAC, their association with
cancer subtypes and `stemness' phenotypes. This Core will support Project 3, by validating earlier observations
in mouse PDAC models by analyzing immune cells and immunomodulatory factors and their association with
genetic subtypes of human PDAC. This Core will also work closely with Core C to enable appropriate human
tissue processing for the innovative CO-Detection by indEXing (CODEX)-based multi-parameter imaging. Thus,
this research core will be highly integrated and supportive of the overall objectives of this Program Project Grant.

Public health relevance
PROJECT NARRATIVE: Stanford Human Bio-bank for Pancreas Cancer Research (Core B) The Stanford Human Bio-Bank for Pancreas Cancer Research is a proposed Core to support the research projects in this Program Project Grant focused on genetic and immune regulation of pancreatic cancer development. This core will systematically collect and bank human tissues and blood from patients with pancreatic cancer and pre-cancerous conditions including chronic pancreatitis. These samples will support human tissue and cell studies that are part of the integrated research projects and support an innovative CO- Detection by indEXing (CODEX)-based multi-parameter imaging Core. In addition to banking bio-specimens, this Core will provide expertise and knowledge of human tissue analysis by histology, immunohistochemistry, and other advanced analytical techniques. This research core will help this Program meet the public health goals of the NCI by providing a translational platform to develop and validate biomarkers for early diagnosis and treatment of pancreatic cancer.